TB Phage therapy: Optimizing delivery methods of mycobacteriophages to target intracellular Mycobacterium tuberculosis

Abstract
Tuberculosis (TB) remains as a major global health problem causing 1.2 million deaths and over 10
million new cases each year. The onset of the HIV epidemic beginning in the late 1980s led to immune
suppression in humans and significantly increased the emergence of drug resistance, lengthening
treatment duration. Ominously, there are strains of M. tuberculosis, the causative agent of TB, that are
resistant to many, if not all, of the currently available TB drugs that are extremely difficult to treat. As an
alternative to drugs, mycobacteriophages - viruses that kill M. tuberculosis, have been considered as
possible agents to treat tuberculosis. However, previous studies have had limited success in mammalian
hosts. The goal of this grant is to elucidate why phage therapy fails to work. We hypothesized that the
major obstacle is mycobacteriophages are unable to come into contact with the M. tuberculosis cells
that live intracellularly. We propose to develop novel strategies to deliver mycobacteriophages to the
intracellular compartments in which M. tuberculosis resides. One approach would be to engineer
mycobacteriophage capsid proteins so that we can add macrophage delivery ligands to promote cellular
uptake. In addition, we plan to explore the use of a Mycobacterium smegmatis strain as a Trojan horse
delivery vector to the intracellular M. tuberculosis. These studies will be enhanced by our ability to
generate mycobacteriophages that express fluorescent reporter proteins. In order to deliver the
mycobacteriophages to the lungs, the site of intracellular localization, we plan to use spray dried
mycobacteriophage powders. We also plan to test the hypothesis that mycobacteriophages may work as
an adjunct therapy with existing TB drugs in mouse models.

Public health relevance
Project Narrative Tuberculosis (TB) remains a global health problem resulting in 1.2 million deaths and 10 million new cases per year. Although drugs exist to cure TB, short course chemotherapy is a minimum six-month regimen. Mycobacterium tuberculosis (the causative agent of TB) strains have developed resistance to all TB drugs and novel therapies are urgently needed. Previous studies have found mycobacteriophages can kill M. tuberculosis suggesting that these organisms could prove to be an invaluable resource to fight this global epidemic The goal of this proposal is to develop strategies to use these mycobacteriophages to shorten chemotherapy and kill drug resistant forms of M. tuberculosis.